PROXIMAL FEMUR BONE REMODELING AS AN OPTIMAL PROCESS

The long term goal of the proposed work would be to develop the most efficient means to reduce fracture risk in an osteoporotic femur given the ability to add a specified amount of bone mass. As an initial study, we propose to investigate the problem using methods of engineering design optimization to examine several pertinent issues. A finite element (FE) model of the proximal femar will be used as the driving function in the optimization procedure. This model was developed from a quantitative CT scan of a 93 year old female from which detailed geometry and local cortical and cancellous bone density was determined. The model consists of 5,745 8-noded linear elastic 3-D elements with 31,293 nodes. Two candidate design objectives are 1) minimizing failure risk with a fixed limit on resources (amount of bone added) and 2) minimizing cost (added bone mass) with a fixed limit on failure risk. Two organizational methods will be investigated: the modified method of feasibl e directions and sequential quadratic programming.